Understanding Biomineralization in Coccolithophores by Comparative Genomic, Transcriptomic and Epigenetic Analyses

Project Summary Coccolithophores are marine phytoplanktons that produce elegantly sculptured calcium carbonate cell coverings known as coccoliths. While coccolith formation is of great interest to areas of material science and medicine, information relating to the genetic and biochemical underpinnings of the biomineralization process in coccolithophores is still lacking. Knowledge of the molecular mechanisms regulating genes and gene products involved in the biomineralization process of coccolithophores may shed light on that of higher organisms, and help to develop strategies to promote healthy mineralization and prevent problems associated with pathological conditions such as rickets, kidney stones, osteoporosis, and ectopic calcification of vascular tissues. Here we propose to improve our understanding of genes and proteins involved in coccolithophorean biomineralization by performing integrated comparative analyses of genomic, transcriptomic and epigenetic data generated from next generation sequencing (NGS). The system for this study consists of three closely related species of Isochrysidales clade of haptophytes: calcifying Emiliania huxleyi (E. huxleyi) and Gephyrocapsa oceanica (G. oceanica), and non-calcifying Isochrysis galbana (I. galbana), as well as E. huxleyi isogeneic strains of M217 (calcifying) and CCMP1516 (non-calcifying). The following specific aims are proposed: Aim 1: Assemble high-quality genomes of G. oceanica and I. galbana by using NGS, and identify key gene and protein groups essential to coccolithophorean biomineralization through integrated study of comparative genomics and transcriptomics. Aim 2: Uncover epigenetic modifications critical to the expression of biomineralization genes. A large amount of NGS data will be generated and computationally analyzed for this study, which help to uncover the genotypic similarity and differences as well as regulatory mechanisms underlying the phenotypic diversities of coccolith formations. The project described here will PI’s current research in bioinformatics, continue to build necessary computational infrastructure and involve more graduate and undergraduate students into bioinformatics research at CSUSM, towards PI’s long-term goal of developing a successful interdisciplinary research/educational program of bioinformatics at CSUSM.

Public health relevance
Project Narrative Coccolithophores are marine algae that produce elegantly sculptured calcium carbonate cell coverings known as coccoliths. Understanding the biomineralization process of coccolith formation will help to develop strategies to promote healthy mineralization and prevent problems of unwanted calcification in higher organisms. The goal of this research is to improve our understating of biomineralization in coccolithophores by analyzing a large amount of genomic, transcriptomic and epigenetic data generated from calcifying and non-calcifying coccolithophore species and cultures.